Mechanistic analysis of activity-dependent BMP/TGF-beta release at a model synaps

DESCRIPTION (provided by applicant): Mechanistic analysis of activity-dependent BMP/TGFβ release at a model synapse How do cells diversify signaling outputs of widely used intercellular signaling pathways? A handful of conserved growth factor pathways mediate communication between cells throughout life. Yet remarkably, the signaling outcomes of these pathways are finely tuned to developmental and cellular context. We will investigate signaling specificity of the BMP/TGFβ pathway. This pathway serves a number of independent functions at the Drosophila NMJ. In particular, it regulates both NMJ morphological growth and neurotransmitter release. We present evidence that the cellular source of the BMP ligand Gbb discriminates between these two pathways. We propose a model in which the single-pass transmembrane protein Crimpy is a sorting receptor for the BMP for dense core vesicles in the regulated secretory pathway. We argue that (1) activity-dependent re- lease of the BMP promotes neurotransmission and (2) Crimpy defines the neuron-derived ligand pool. BMP/TGFβ family members are synaptically localized and subject to activity-dependent release in mammalian neurons. However, the cellular mechanisms responsible for their localization to dense core vesicles are opaque. Crimpy would represent the first BMP/TGFβ dense core vesicle sorting receptor identified in any system. Given clinical interest in identifying tools to selectively target synaptic functions of growth factor signaling pathways, a mechanistic understanding of Crimpy and its mammalian homologs will be of significant interest.

Public health relevance
Growth factors have diverse synaptic functions-regulating plasticity, morphology, active zone organization, neurotransmitter release, and synaptic homeostasis. We are investigating mechanisms conferring signaling specificity to the BMP/TGFβ pathway at the Drosophila NMJ. We find that the BMP ligand is regulated by activity and is delivered to the presynapse by a transmembrane protein named Crimpy. We propose that Crimpy is a sorting receptor for the BMP for vesicles in the regulated secretory pathway. BMP/TGFβ family members signal at synapses in many species, yet the cellular mechanisms driving this localization are unknown. As such, Crimpy would represent the first TGF/BMP sorting receptor in any species. Given clinical interest in identifying molecular handles to selectively targets synaptic functions of growth factor signaling pathways, a mechanistic understanding of Crimpy and its mammalian homologs will be of significant interest.